Research Program: Cancer Risk and Control (CRiC)

ABSTRACT: CANCER RISK AND CONTROL PROGRAM (CRiC)
The Cancer Risk and Control (CRiC) Program identifies disparities in population-based cancer risk and
outcomes, creates behavioral interventions to improve outcomes, and develops implementation strategies to
diminish morbidity and mortality from cancer. The CRiC Program’s aims to: 1) Discover the individual, molecular,
structural, and community factors that impact cancer risk and outcomes across the cancer continuum; 2) Develop
behavioral interventions to mitigate cancer risk and improve cancer outcomes; and 3) Implement programs that
positively impact health systems and develop strategies towards improving quality of life in cancer survivors.
CRiC members have generated paradigm-shifting findings that have enabled application of scientific advances
to the translational pipeline, resulting in changes in public health policy and improved standards of care in the
clinical setting. CRiC promotes transdisciplinary research through inter-programmatic collaborations with
members in the other three Programs of the Sidney Kimmel Cancer Center (SKCC). The scientific findings of
CRiC inform interventional studies that address the high incidence and mortality and/or disparity of the top
cancers identified in the SKCC strategic plan that is facilitated by partnership with COE. Members are highly
engaged in the development of trainees through multiple mechanisms including conference presentations and a
minority pipeline research program.
The CRiC Program is led by Nicole Simone, MD, and Terry Hyslop, PhD, who provide complementary expertise
in behavioral interventions to improve cancer outcomes, and the development of computational frameworks in
the study of cancer disparities, respectively. To capture the research strengths across the consortium, the
Program assembles 33 members from 15 departments across Thomas Jefferson University and Drexel
University. CRiC members have successfully published and obtained grant support. Total cancer relevant
funding is $15.2 M with $5 M from NCI and a further $5.8 M from other NIH institutes and DOD. CRiC has
published 867 cancer-relevant research articles of which 18% are intra-programmatic, 17.7% are inter-
programmatic, and 49.9% are collaborative with other NCI-designated Cancer Centers. Important discoveries
have been published in high-impact journals including J Clin Oncol, N Eng J Med, and Lancet Planetary Health.
CRiC aims to make an immediate and major impact on population health, quality of life, and survivorship across
the catchment area.
The CRiC Program’s future directions are aligned to the SKCC strategic plan, IMPACT PHL. Future goals are
to: 1) Enhance programmatic approaches into new areas of disparities research; 2) Increase community
member-informed research to address catchment area needs; and 3) Recruit members focused on structural
racism, disparities, healthcare access, and associated policies.